BUP - BOOSTeR: Behavioral Optimization for Overcoming Suboptimal Treatment Retention

PROJECT SUMMARY/ABSTRACT
Buprenorphine, a medication for opioid use disorder (MOUD), is associated with decreased opioid overdose
and all-cause mortality. Treatment outcomes improve if patients remain on MOUD for at least six months, a
period recommended by expert guidelines. Despite this, most studies report retention on MOUD of 50-65% at
3-6 months, with most treatment drop out occurring during the first month of treatment. Psychosocial
interventions have the potential to improve OUD treatment retention particularly when applied in
combination in efficient delivery systems. The objective of this study is to develop an effective and efficient
multicomponent intervention to increase buprenorphine retention at 6 months through an optimization trial. We
will leverage the Multiphase Optimization STrategy (MOST) framework for developing, optimizing, and
evaluating a multicomponent behavioral intervention. We will test the impact of three psychosocial intervention
components on buprenorphine treatment retention at six months by recruiting 240 persons initiating
buprenorphine from office-based addiction treatment settings and randomizing them in a balanced 23 factorial
design to 1) Brief advice to continue treatment for at least 6 months (usual care); 2) Behavioral-Activation
(BA)—focused on increasing positive reinforcing activities and experiences to promote recovery; 3)
Attendance Reinforcement (AR)— incentivizing attendance at nurse visits in addiction care; and 4) Peer
Motivational Interviewing (Peer-MI) –increasing confidence to continue buprenorphine treatment and
providing social support. The observed main and interaction effects for the 3 candidate psychosocial
interventions will guide the selection of components to be included in an optimized intervention. Using
mediation analyses, we will examine whether each component affects the hypothesized mechanism of action
and whether hypothesized mechanisms account for observed changes in buprenorphine retention. Results
from this study will be twofold: 1) it will improve our understanding of mechanisms by which psychosocial
component interventions improve buprenorphine MOUD treatment retention and 2) prepare the
scientific team to conduct a future randomized controlled trial of the optimized intervention package.
The long-term impact will be to establish tangible and disseminatable methods to improve MOUD
retention.

Public health relevance
PROJECT NARRATIVE Despite extensive evidence of the effectiveness of buprenorphine to improve health outcomes and reduce mortality for people with opioid use disorder, only 50-60% of people remain on treatment at 6 months. This proposal will leverage the Multiphase Optimization STrategy (MOST) framework for developing, optimizing, and evaluating a multicomponent behavioral intervention by testing the impact of three psychosocial intervention components on buprenorphine treatment retention at six months. The results of this study will inform the development of an efficient and effective treatment package to increase buprenorphine retention with the potential for broad health benefits for persons with opioid use disorder.